2024 Laboratory Flexible Funding Model Meeting

FOA PAR-23-072
2024 Laboratory Flexible Funding Model Meeting
Summary
APHL has the experience and competence to effectively host a high-quality Laboratory
Flexible Funding Model (LFFM) Meeting in the south-central U.S. in February of
2024 using the approach described in the proposal. This meeting will allow scientists
who are funded through FDA's LFFM but located across the U.S. to interact with FDA
funding partners and other leaders to exchange the latest information related to testing
under the chemistry, microbiology, and radiochemistry LFFM tracks. Interactions of this
nature in the setting of the LFFM Meeting will enable public health and regulatory
officials to improve available testing data on food contamination and reduce foodborne
illnesses and deaths. This purpose aligns with ORA's commitment to build integrated
laboratory capacity and capability and support the generation of defensible state data
for regulatory action.

Public health relevance
FOA PAR-23-072 2024 Laboratory Flexible Funding Model Meeting Project Narrative The Laboratory Flexible Funding Model (LFFM) Meeting will allow scientists who are funded through FDA's LFFM cooperative agreement to interact with FDA funding partners and other food safety leaders to exchange information related to approved testing under the chemistry, microbiology, and radiochemistry LFFM tracks. The meeting is the only face-to-face opportunity for participants to connect with other grantees to hold focused discussions on the science and collaborative efforts that ensure the success of the LFFM program. deaths. The meeting's purpose aligns with ORA's commitment to build integrated laboratory capacity and capability and support the generation of defensible state data for regulatory action.